Tools to Visualize and Summarize HIV Resources, Disease Burden and EHE Interventions in Miami-Dade County

This project, which provides foundational work to support the four pillars (Diagnose, Treat, Prevent, and Respond) of the United States Ending the HIV Epidemic (EHE) plan, brings together Florida’s Miami-Dade County Department of Health, Miami’s Developmental AIDS Research Center (CHARM; P30MH116867) and the Miami Center for AIDS Research (CFAR; P30AI073961) to build tools that provide state-of-the-science visualization and summaries of care resources, disease burden and responses to community-based interventions that are part of the EHE efforts. Currently, information on disease burden in Miami-Dade, one of the counties with the highest HIV disease burden in the United States, is years out of date and is summarized at the county level and for some zip codes. The primary aim of this project is to produce more timely and complete geographically-focused summaries of disease burden and HIV care success. These disease details will be integrated with geolocated information on HIV service providers and published as stand-alone visualizations/summaries and as part of both the public facing SCAN360 website and the Florida Health Charts web portals.24 SCAN360 already provides interactive maps and other visualizations along with tables describing cancer disease burden, cancer screening, general health-promoting and disease risk factors, and demographic information for hundreds of places across Florida. Modern visualization methods such as Value- Suppressing Uncertainty Palettes will be deployed to help a broad audience including researchers, policy makers and community members to understand places which need to be targeted for additional EHE efforts. The second aim is to build researcher- and community-based organization-facing tools to support data-driven feedback for the development and evaluation of community and neighborhood-specific interventions using geospatially-driven interventions feedback to address EHE. Dissemination efforts will be assessed using the Consolidated Framework for Implementation Research (CFIR) and focuses on training and education, interactive assistance and the development of a learning collaborative with local CBOs and Researchers. Longer-run dissemination and implementation of these data tools and data-driven feedback (including the continuation of the learning collaborative) will be provided and documented by the CHARM Methods core (led by Drs. Balise and Feaster) and trainees associated with CHARM through the newly funded CHANGE T32 Training Program (T32MH126772). This group will lead CHARM’s efforts to sustain the learning collaborative and ensure adequate adoption of data-driven feedback to effect HIV outcomes in South Florida. In conclusion, this project describes HIV today and will guide future interventional projects and service provision to the places with the greatest need in Miami-Dade, and will serve as a proof-of-concept to expand place-specific summaries for all of Florida.

Public health relevance
By bringing together Florida’s Miami-Dade County Department of Health (DOH), Miami’s Developmental AIDS Research Center (CHARM; P30MH116867) and the Miami Center for AIDS Research (CFAR; P30AI073961), this project will provide community members, policy makers and researchers with timely summaries of HIV disease burden and service providers in 75 places across Miami-Dade County, one of the places with the worst HIV disease burden in the United States. These summaries will afford the opportunity to measure responses to community-based interventions long before the currently available HIV disease burden summaries provided by the DOH, which currently take years to aggregate and disseminate, are available. This project focuses on HIV information in Miami-Dade County, it will provide the template for information dissemination from other counties by both the Florida Department of Health and the SCAN 360 web portal.24